Secretagogue and Gi/o-GPCR signaling through the islet Na+/K+-ATPase in health and diabetes

Project Summary
Islet glucose-stimulated insulin and somatostatin (SST) secretion are perturbed in patients with type-2 diabetes
(T2D) and in animal models of the disease, which contributes to disrupted glucose homeostasis. It is generally
accepted that secretagogues stimulate hormone secretion from -cells and -cells in response to elevated intra-
cellular Ca2. However, the mechanisms that control inhibition of islet Ca2+ handling via Gi/o-coupled receptors
(Gi/o-GPCRs) and how they are altered in T2D are largely unknown. Data from our lab finds that Gi/o-GPCRs
reduce islet Ca2+ entry via Src tyrosine kinase-mediated activation of Na+/K+-ATPase (NKA), which
hyperpolarizes membrane potential (Δψp) and limits insulin secretion. Further data show that Protein kinase A
(PKA) activation by Gs-coupled receptors inhibits islet NKA activity and stimulates Ca2+ entry. Moreover, we find
that islet SST provides paracrine signaling that slows glucose-stimulated -cell Ca2+ oscillations via oscillations
in NKA activity, which depends on the action of Src tyrosine kinase and PKA. Finally, our preliminary data provide
the first evidence that diabetic conditions diminish islet NKA activity, which contributes to perturbations in glucose
and GPCR control of Ca2+ handling. Based on these exciting preliminary data, the overall objective of this pro-
posal is to elucidate how islet NKA is controlled and becomes disrupted during the pathogenesis of diabetes.
This project will test the central hypothesis that that islet NKA activation by tyrosine kinases limits Ca2+ entry and
hormone secretion through Δψp hyperpolarization; whereas, PKA inhibition of islet NKAs enhances Ca2+ entry
and hormone secretion by depolarizing Δψp. The rationale that underlies this project is that understanding sig-
naling that integrates NKA modulation of islet cell Ca2+ handling and hormone secretion will expose novel thera-
peutic targets for restoring glucose-stimulated hormone secretion in T2D. This project will be accomplished with
the following two specific aims: 1) Determine the mechanisms regulating NKA control of β-cell function in health
and diabetes; and 2) Determine how NKA modulates -cell function and dysfunction. Under the first aim, trans-
genic mice with -cell ablation of the - - and -subunits of the NKA complex subunits as well as human -cells
with knockdown of NKA - - and -subunits will be utilized to assess the roles of NKA during secretagogue and
Gi/o-GPCR modulation of -cell Ca2+ handling and insulin secretion. Aim1 will also determine how diabetic con-
ditions impact NKA signaling and insulin secretion. Under the second aim, NKA control of -cell Ca2+ handling
and function will be determined in mice with -cell specific ablation of NKA - - and -subunits or in human
pseudoislets with -cell specific knockdown of NKA - - and -subunits. Furthermore, Aim2 will determine how
reduced NKA function in -cells under the stressful conditions associated with diabetes contributes to -cell
dysfunction. This project is significant because it is expected to illuminate mechanisms that alter -cell and -cell
Ca2+ handling and disrupt islet hormone secretion in T2D. Moreover, this project plans to identify potential phar-
macological strategies for normalizing islet hormone secretion and reducing islet dysfunction in T2D.

Public health relevance
Project Narrative The proposed project will determine mechanisms that control -cell and -cell Na+/K+-ATPase activity and how they regulate Ca2+ handling as well as islet hormone secretion. Results from this project are also expected to provide significant mechanistic insights into disruption of islet Ca2+ handling and hormone secretion in T2D in the context of perturbed glucose control and GPCR regulation of Na+/K+-ATPase function. Thus, the proposed research project will generate fundamental knowledge about human islet function and dysfunction that will help reduce the burden of human illness in the context of diabetes.